A small RNA regulation of virulence in Lyme disease pathogen

Project Summary/Abstract
Lyme disease, a prevalent arthropod-borne disease, is caused by the bacterial pathogen Borrelia burgdorferi.
The microbes live in an intricate enzootic life cycle involving both Ixodes ticks and diverse mammalian species.
To survive in its complex cycle and navigate through disparate sets of tissue environments, such as ones in
mammalian hosts or in ticks, B. burgdorferi must regulate gene expression in a tight temporal and spatial
manner, although the mechanism of such gene regulation remains unclear. Posttranscriptional gene
regulation via a variety of small regulatory RNAs (sRNAs) is one mechanism of modulating gene expression in
bacteria. Base pairing between the sRNAs and target mRNAs can trigger alterations in mRNA translation and
stability, thereby influencing target gene expression. The small RNAs also bind to proteins, either sequestering
or affecting the activities of proteins. Previous studies have reported that a small RNA, DsrABb, regulates RpoS
gene expression in B. burgdorferi. Moreover, recent studies identified over 1000 B. burgdorferi sRNAs that are
differentially regulated by environmental conditions, suggesting that sRNAs may play a role in gene regulation
for spirochete adaptation during its enzootic cycle, although their precise functions or importance in spirochete
biology and infectivity remain largely enigmatic. Most recently, an intergenic non-coding small RNA located
upstream of bbd18, called ittA, was characterized and shown to be required for optimal infectivity and tissue
tropism in B. burgdorferi. In fact, the intergenic region of bbd17 and bbd18 was reported to harbor a small
RNA 0735 (SR0735), that is highly expressed at 37°C (mammalian host body temperature). Our preliminary
data showed that the insertion of a kanamycin cassette upstream of SR0735 affects B. burgdorferi infectivity
and decreases the level of SR0735, as shown in Northern blot and RT-PCR analyses, suggesting a critical
importance of SR0735 in microbial virulence. The goals of our current proposal are to study the potential role
of this sRNA in spirochete biology and virulence, and to identify its potential target RNA and/or protein binding
partners. This study will uncover the sRNA regulatory mechanisms in spirochete biology and may help to
decipher the functions of sRNAs in spirochete virulence and pathogenesis.

Public health relevance
Project Narrative Borrelia burgdorferi, the Lyme disease pathogen, survives in an intricate enzootic life cycle involving Ixodes ticks and mammals. Although the pathogen is shown to regulate gene expression in response to environmental changes, the mechanism of gene regulation is not clear. The current proposal aims to investigate the potential role of small RNA 0735 (SR0735) in spirochete gene regulation and virulence, and to identify its potential target RNA and/or protein binding partners, which will uncover sRNA regulatory mechanisms in spirochete biology, and may help to decipher their functions in spirochete virulence and pathogenesis.